A reagent kit for spatial transcriptomic analysis

Project Summary
Recent advances in massively parallel single cell genomic techniques have enabled
researchers to study genomic and gene expression in high resolution. However, these
techniques do not preserve spatial context of individual cells within the tissue and can bias
representation of various cell types due to cell dissociation that is required before application of
the techniques. Commercial availability of spatial genomic techniques is sparse. We have
recently founded Atlas Bio with the academic inventors of the Slide-Seq technique in order to
commercialize the technology. Slide-Seq is an easy-to-use yet sensitive method for measuring
spatial transcriptomes in tissue slices, first published in 2019 (Rodriques SG et. al, Science
2019). The technique makes use of a spatially barcoded bead substrate, a set of enzymatic
reagents and buffers, and a custom bioinformatics pipeline. It does not require any special
instrumentation other than access to a next-generation sequencer. In the first two months of
operation of the company, we have successfully replicated the production of the Slide-Seq
spatially barcoded substrates and tested their performance. The goal of the proposed Phase II
project is to further develop the Slide-Seq technology such that it can be widely disseminated
and can be expanded to different applications such as those that require high spatial resolution
and detection sensitivity. Specifically, the project will address the scalability, robustness, and
manufacturability of the spatially barcoded substrate, which is the key component of the
technique. We will also develop solutions to facilitate easy dissemination of the technology
through development of consumables, reagent kits, bioinformatics pipeline, and basic data
visualization tools, with the goal to lower the barrier of entry to spatial transcriptomic analyses.
Lastly, we will work on improving the performance of the spatial transcriptomic technique in
terms of spatial resolution and sensitivity, and expand the workable tissue type from fresh frozen
to FFPE. By standardizing the technique through commercialization and making it available to a
wider audience, we hope to accelerate a new wave of biological discoveries.

Public health relevance
Project narrative To develop a simple, easy-to-use assay kit for analyzing the spatial transcriptomes of tissues. The commercial availability and standardization of this technique will lower the barrier of entry to study complex biologies, enabling researchers to understand how cells work together in their environment down to the single-cell level. Such studies would enable researchers to gain additional understanding of the architectures inside tissues in normal and diseased states, particularly in the areas of neuroscience and oncology, and assist discoveries of new biomarkers.